Population Research Training

ABSTRACT
Patterns of reproductive health, fertility, investment in children, morbidity, and mortality vary substantially by
age, race, ethnicity, gender, economic status, and other axes of stratification—a reality that emerged
particularly clearly during the COVID-19 pandemic. The methods and approaches of population science, which
are rooted in the tools of demography but draw also from empirical approaches of biostatistics, epidemiology,
and economics, are essential for understanding the causes and consequences of these patterns of population
health and well-being. In this renewal application, we propose continuation of the multidisciplinary and
interdisciplinary Population Science Training Program housed at the Carolina Population Center. The goal of
the program is to train the next generation of population scientists to conduct critical research on the causes
and consequences of population change and the implications for health and well-being across the globe.
Cross-disciplinary collaboration and hands-on involvement in innovative population science research are
defining features of our program. Our training faculty represent 11 different academic departments, roughly
balanced between social science and public health disciplines; our trainees themselves are equally diverse.
The predoctoral program combines disciplinary PhDs with a strong grounding in population science through
coursework, seminars, and workshops and a mentored research practicum with one or more faculty members
that continues throughout training. The postdoctoral program is structured around a close mentoring
relationship between the training faculty and postdoctoral scholars, customized to fit the goals and interests of
both. We seek continued support for seven predoctoral trainees and two postdoctoral scholars, a level well-
justified by the competitiveness of the current program and the outstanding productivity and placement of prior
trainees. With substantial guidance from the training director, training manager, and their faculty preceptors,
trainees in our program leave with the subject matter expertise, interdisciplinary orientation, team science
approach, data skills, and population perspective to conduct creative and rigorous research to improve human
health and well-being in the US and beyond.

Public health relevance
PROJECT NARRATIVE The NICHD/NRSA-supported Population Science Research Training Program, housed at UNC’s Carolina Population Center, combines disciplinary PhDs with interdisciplinary predoctoral and postdoctoral training in demography and population science. Hallmarks of this longstanding program are: the integration of social and health sciences, an outstanding and experienced training faculty from 11 departments in the College of Arts & Sciences and the Gillings School of Global Public Health, the interdisciplinary team orientation of much of the training and research, and a well-established track record of success in the recruitment, training, and placement of trainees.